Bruker timsTOF HT Mass Spectrometer to Support Proteomics Research in the Georgia Tech Core Facilities

Project Summary: We request funds to purchase a Bruker timsTOF HT mass spectrometer with a nanoElute 2
UHPLC system and accompanying operation software for the Systems Mass Spectrometry Core (SyMS-C)
proteomics facility (SyMS-C PF) at Georgia Tech, replacing the obsolete Orbitrap instrumentation currently used
for proteomics analysis. This essential upgrade will support several existing major and minor NIH-funded users
and other proteomics projects across Georgia Tech and surrounding Atlanta labs. The new timsTOF HT
instrument, combining ion mobility spectrometry (IMS) and mass spectrometry (MS), is backed by literature
evidence for performance improvements in proteomics analysis as well as extensive pilot studies conducted by
PI Torres' lab. These improvements are crucial for improving the rigor of NIH-funded proteomics studies
conducted by the SyMS-C PF using 9 year-old instrumentation that is nearly obsolete and frequently in disrepair.
The timsTOF HT LCMS system offers significant enhancements in sensitivity, specificity, selectivity, dynamic
range, and throughput, meeting the critical analytical needs of 15 major and minor users at Georgia Tech. The
instrument was chosen over other systems based on user needs at Georgia Tech, performance comparisons on
core facility samples, the need for accessible IMS instrumentation in the Atlanta area, and favorable pricing that
maximizes value for Georgia Tech and NIH. Evidence supporting these factors is detailed in the application to
justify acquiring an IMS-MS instrument to serve NIH-sponsored and other users for the next 5 years and beyond.
Importantly, strong institutional commitment will provide the requisit service for the entire LCMS system, a
technical director with over 12 years of expertise in MS-based proteomics, a research technician to support
operations, a dedicated space for sample handling and MS operations, as well as modern AI-based software
demonstrated to improve LCMS performance beyond the capacity of stock software alone.

Public health relevance
Project Narrative: Improvements in human medicine are derived from improvements in our understanding of how cells function and communicate to one another. Proteins, molecules that are produced by the DNA in a cell such as enzymes and receptors, are essential for the function of cells and also serve as the targets of drugs used to treat disease. This grant application will support the acquisition of a highly sensitive instrument that allows researchers to study and better understand proteins, their importance to cellular function, and their ability to serve as targets for new medicines that treat disease.